Optimizing HEALing in Ohio Communities (OHiO)

PROJECT SUMMARY
The opioid epidemic has become entrenched in Ohio, with an age-adjusted opioid-related overdose death rate
of 32.9/100,000 people (2017), ranking second nationally. Neither rural nor urban areas have been spared,
with 38 of Ohio’s 88 counties (43%) reporting opioid-related deaths exceeding 25/100,000 people.
Since 2012, Ohio has mounted an unprecedented effort to reduce opioid use disorder (OUD) morbidity and
mortality through policies and investments in prevention, treatment, and recovery efforts. However, challenges
inherent in integrating and deploying evidence-based interventions (EBI) across sectors has limited their
impact in affected communities.
The goal of Optimizing Healing in Ohio Communities (OHiO) is to systematically plan, implement, and evaluate
data-driven approaches that integrate multi-pronged EBI within healthcare, behavioral health, justice systems,
and communities to reduce opioid overdose deaths in 19 highly affected counties by 40% in 3 years. OHiO is
anchored by three NCATS-funded CTSAs and the NIDA-funded Ohio Valley Node of the Clinical Trials
Network and leverages extensive existing collaborations with community coalitions, state and county
governments, and healthcare, behavioral health and criminal justice sectors. OHiO’s approach is based upon
and aligned with the state-mandated Community Health Assessments and Community Health Improvement
Plans, leveraging state and federally funded programs already in place. The overarching goal will be met
through completion of three aims. Aim 1) Plan: We will assess current policies/programs regarding OUD,
opioid misuse, and opioid-related fatalities; using the Exploration, Adoption/Preparation, Implementation and
Sustainment model, work with communities to select EBI to reduce OUD and overdose deaths; and identify
gaps in services/service coordination that are amenable to intervention. Aim 2) Implement: Through a
pragmatic community-based clinical trial, we will deliver EBI packages using a cluster stepped-wedge design in
which collaborating communities are randomized by the timing of which selected interventions are received.
Aim 3) Evaluate: We will continuously collect and analyze data using the Reach, Efficacy, Adoption,
Implementation, and Maintenance (RE-AIM) model to assess the impact of the integrated interventions and
implementation outcomes including acceptability, adoption (including fidelity to the intervention), feasibility,
penetration, and incremental cost and cost-effectiveness of the multipronged approach. We will also establish
Learning Health Communities to provide community stakeholders access to real-time, actionable information.
Ultimately, OHiO will provide rigorous and reproducible evidence of the effectiveness of integrated prevention,
treatment, and recovery programs in the community context; an exportable and scalable model of service
assessment, community-engaged decision-making; and integrated, data-driven EBI that can be implemented
by affected communities in Ohio, the region, and across the US.

Public health relevance
PROJECT NARRATIVE Optimizing Healing in Ohio Communities (OHiO) will implement and evaluate the effectiveness of an integrated set of evidence-based prevention, treatment, and recovery programs for opioid use disorder in 19 highly affected urban and rural counties in the state. In collaboration with community stakeholders and state and county governments, and anchored by universities across the state, OHiO aims to reduce opioid overdose deaths by 40% in the affected communities in 3 years. The effectiveness of the evidence-based interventions will be disseminated as a model that can be implemented by affected communities across the nation.